Project 2: The cohesin complex as a tumor suppressor in myeloid leukemia

SUMMARY - PROJECT 2 (MELNICK)
Most B-cell lymphomas arise from germinal center (GC) B-cells, which form transiently after T-cell dependent
antigen stimulation. GC B-cells undergo massive proliferation and genomic instability occurring as a byproduct
of immunoglobulin somatic hypermutation, which puts them in danger of malignant transformation. The
phenotypic shift from quiescent naïve B-cells to proliferative and unstable GC B-cells is massive, rapid, and
involves differential expression of thousands of genes. GC B-cells are evanescent, and quickly undergo
terminal differentiation to plasma cells (or undergo apoptosis) after antigen presentation. The most common B-
cell lymphomas (DLBCL and FL) in essence are GC B-cells that have continued to aberrantly persist and fail
to undergo terminal differentiation. We are interested in how these dramatic changes in phenotypes occur,
and how this process can be corrupted to cause lymphoma. To understand the mechanistic basis of the GC
B-cell phenotype we performed genome-wide chromosomal conformation capture (Hi-C, 4C) along with ChIP-
seq for histone marks, cohesin and TFs at different timepoints during B-cell development. We observed truly
massive shifts in chromosomal architecture in GC B-cells including but not limited to i) increased promoter
connectivity, ii) formation of novel enhancer loops, iii) 5' to 3' gene looping, iv) merging of discrete boundary
delimited gene neighborhoods to form larger gene “cities resulting in de novo epigenetic coordination between
genes formally isolated from one another, and v) establishment of GC B-cell specific locus control regions
(LCRs) that control hundreds of GC B-cell gene enhancers (Bunting et. al. Immunity 2016). Strikingly, all of
these architectural changes were tightly associated with cohesin complex redistribution and notably, we
observed recurrent somatic mutation or deletion of the cohesin unloading protein PDS5B in public lymphoma
genomic profiling datasets. Our pilot studies suggest that PDS5B regulates genes involved in exiting the GC
reaction and terminal differentiation. Preliminary experiments in PDS5b knockout or point mutant mice, point
to disruption of GC dynamics and blockade of GC exit. Based on these considerations we hypothesize that
PDS5B is required to unload the GC specific cohesin distribution state so that the GC B-cell transcriptional
program can be extinguished and allow for a different configuration that favors plasma cell differentiation. We
predict that specific signals received from GC T-cells in the GC light zone directly induce PDS5B-dependent
cohesin redistribution. We propose that genetic lesions of PDS5B cause the genome to become architecturally
stuck in the GC configuration thus blocking epigenetic reprogramming required for terminal differentiation and
leading to malignant transformation. We hypothesize that cohesin blockade may be nonetheless reversible
and targetable by drugs that can erase GC/lymphoma epigenetic programming. This proposal will thus define
the role and mechanism of action of dynamic cohesin complex remodeling in the humoral immune response
and lymphomagenesis, and develop novel cohesin therapy approaches.

Public health relevance
NARRATIVE - PROJECT 2 (MELNICK) We discovered a central role for chromosomal conformation in germinal center B-cells during the humoral immune response, linked to massive remodeling of cohesin complexes throughout the genome. Most lymphomas arise from germinal center B-cells, and these tumors are among those that most frequently manifest genetic lesions of the PDS5B cohesin unloading gene. This proposal will define for the first time the role of cohesin unloading dynamics in the humoral immune response and how its perturbation causes malignancy, which will lead us to therapies that could reverse these oncogenic effects.